Subclinical Atherosclerosis in HIV plus Black Cocaine Users

DESCRIPTION (provided by applicant): People who are infected with HIV, especially those on long-term antiretroviral therapy (ART) or who use cocaine, have a high prevalence of LV dysfunction. Since ART use could lead to diabetes, and since cardiac steatosis (fatty heart) has been identified in those with diabetes, it is critical to examine whether HIV infection, ART use, and cocaine use promote cardiac steatosis, a marker for cardiomyopathy. Virtually no reported studies have addressed the combined effects of HIV infection, ART use, and cocaine use on the etiology of cardiomyopathy. According to our preliminary study, cardiac steatosis is prevalent in HIV-infected individuals, especially those on ART. These results are entirely new and never before reported. This application seeks support for conducting novel research on the effects of HIV infection, ART use, and cocaine use on cardiac steatosis. The proposed study, using the cohort of study participants enrolled in the ongoing study DA12777, will employ magnetic resonance imaging (MRI) to accurately quantify the ectopic fat deposition in the myocardium and will explore the association between HIV infection, ART use, cocaine use, and cardiac steatosis. The proposed specific aims of this study are (1) To estimate the prevalence and incidence of cardiac steatosis and left ventricular (LV) dysfunction in cardiovascularly asymptomatic men and women with one of the following characteristics: HIV(-) and cocaine(-); HIV(-) and cocaine(+); HIV(+) and cocaine(-) and ART(-); HIV(+) and cocaine(-) and ART(+); HIV(+) and cocaine(+) and ART(-); and HIV(+) and cocaine(+) and ART(+); (2) To examine the effects of HIV infection on the presence and development of cardiac steatosis and regional LV dysfunction; (3) To examine the effects of the various classes of ART and individual ART on the presence and development of cardiac steatosis and regional LV dysfunction in HIV-infected persons; (4) To examine the effects of cocaine use on the presence and development of cardiac steatosis and regional LV dysfunction; (5) To examine the joint effects of HIV infection, ART use, and cocaine use on the presence and development of cardiac steatosis and regional LV dysfunction; and (6) To investigate the direct effects and mechanisms of HIV infection, ART use, and cocaine use on mitochondrial damage. This study will be among the first, if not the very first, to explore the mechanisms of premature HIV/cocaine-related cardiomyopathy, and its findings may lead to a breakthrough in research on prevention/intervention related to heart failure in HIV-infected persons and to translation of scientific discoveries into clinical applications.

Public health relevance
PUBLIC HEALTH RELEVANCE: This study will investigate why HIV-infected African Americans have high rates of cardiac steatosis and regional left ventricular dysfunction. The study could provide critical information for understanding the mechanisms of premature heart failure and lead to a breakthrough in research on prevention/intervention of heart disease in HIV-infected persons and to translation of scientific discoveries into clinical applications. This study will investigate why HIV-infected African Americans have high rates of cardiac steatosis and regional left ventricular dysfunction. The study could provide critical information for understanding the mechanisms of premature heart failure and lead to a breakthrough in research on prevention/intervention of heart disease in HIV-infected persons and to translation of scientific discoveries into clinical applications. __SpecificAimsTextDelimiter__ A. SPECIFIC AIMS Despite recognition that HIV infection and cocaine abuse are associated with an increased risk of developing cardiovascular complications, most investigations have focused on atherosclerotic coronary artery disease (CAD), not on heart failure. Virtually no reported human studies have addressed the combined effects of HIV infection, antiretroviral therapy (ART), and cocaine use on the etiology of early cardiomyopathy. Cardiomyopathy is disease of the heart muscle. The most common manifestation of cardiomyopathy is heart failure. In the past 9 years, the results derived from the ongoing study, entitled "Subclinical atherosclerosis in HIV+ black cocaine users" (DA12777), not only demonstrated that both cocaine alone and HIV infection alone are associated with subclinical atherosclerosis, but also showed a trend suggesting concomitant exposure to both cocaine and HIV infection may further exacerbate the atherosclerosis associated with either factor alone. Furthermore, according to our preliminary investigation, cardiac steatosis, a new marker for left ventricular dysfunction, is prevalent in HIV-infected cardiovascularly asymptomatic individuals, especially in those on ART containing protease inhibitors (PIs). These results are entirely new and never before reported. This application seeks continued support for conducting a study to investigate the prevalence and incidence of cardiac steatosis and its risk factors using the cohort set up by the grant DA12777, which is a longitudinal study performed in Baltimore, Maryland. With the use of advanced laboratory and imaging technologies, the proposed study will not only estimate the rates of cardiac steatosis and identify its risk factors for prevention, but also investigate the underlying mechanisms of early cardiomyopathy - the direct effects of HIV infection, ART, and cocaine use on early cardiomyopathy in cardiovascularly asymptomatic African Americans (AAs). In sum, this is a hypothesis-driven longitudinal study focusing on the mechanisms of early initiation and progression of cardiomyopathy in HIV-infected individuals. The specific aims of our proposed study are as follows: SPECIFIC AIM 1. To estimate the prevalence and incidence of cardiac steatosis and left ventricular (LV) dysfunction (both regional dysfunction and global dysfunction) in cardiovascularly asymptomatic men and women with one of the following characteristics: HIV(-) and cocaine(-); HIV(-) and cocaine(+); HIV(+) and cocaine(-) and ART(-); HIV(+) and cocaine(-) and ART(+); HIV(+) and cocaine(+) and ART(-); and HIV(+) and cocaine(+) and ART(+); We will estimate not only the overall prevalence and incidence of cardiac steatosis and LV dysfunction, but also their prevalence and incidence by age, sex, race, HIV viral load level (d400 vs. >400), blood pressure (BP; hypertensive vs. normotensive), presence of coronary plaques, severity (<50% vs. e50%) of stenosis, duration of cocaine use, and duration of ART use (NRTI, NNRTI, or PI). SPECIFIC AIM 2. To examine the effects of HIV infection on the presence and development of cardiac steatosis and LV dysfunction. Hypothesis 1. HIV infection is associated with the presence and development of cardiac steatosis and LV dysfunction. Hypothesis 2. Among HIV-infected persons, a higher HIV viral load is associated with the presence and development of cardiac steatosis and LV dysfunction. Hypothesis 3. Among HIV-infected persons, immune activation measured by CD4 nadir is associated with the presence and development of cardiac steatosis and LV dysfunction. Hypothesis 4. Among HIV-infected persons, platelet activation is associated with the presence and development of cardiac steatosis and LV dysfunction. SPECIFIC AIM 3. To examine the effects of the various classes of ART and individual ART on the presence and development of cardiac steatosis and LV dysfunction in HIV-infected persons. Hypothesis 5. ART (all classes) use is associated with the presence and development of cardiac steatosis and LV dysfunction in HIV-infected persons. Hypothesis 6. Duration of ART use is associated with the presence and development of cardiac steatosis and LV dysfunction in HIV-infected persons. Since not all ARTs may have adverse effects on cardiac steatosis and regional LV dysfunction, the hypotheses involving ART use will also be tested for individual ARTs. SPECIFIC AIM 4. To examine the effects of cocaine use on the presence and development of cardiac steatosis and LV dysfunction. Hypothesis 7. Cocaine use is associated with the presence and development of cardiac steatosis and LV dysfunction. Hypothesis 8. Long-term cocaine use is associated with the presence and development of cardiac steatosis and LV dysfunction. SPECIFIC AIM 5. To examine the joint effects of HIV infection, ART use, and cocaine use on the presence and development of cardiac steatosis and regional LV dysfunction. This aim will address the main objective of this study - to explore whether HIV infection, ART use, and cocaine use potentiate their cardiotoxic effects. There are three hypotheses under this aim. Hypothesis 9. Long-term ART use and long-term cocaine use have synergistic effects on the presence and development of cardiac steatosis and LV dysfunction. Hypothesis 10. HIV infection and long-term cocaine use have synergistic effects on the presence and development of cardiac steatosis and LV dysfunction. Hypothesis 11. Low 25-hydroxyvitamin D level is independently associated with the presence and development of cardiac steatosis and LV dysfunction. SPECIFIC AIM 6 (Addressing mechanisms). To investigate the direct effects and mechanisms of HIV infection, ART use, and cocaine use on mitochondrial damage. Total mtDNA and the ratio of mitochondrial DNA to nuclear DNA (mtDNA:nDNA) will be measured and used to quantify mitochondrial damage. With this aim, we will investigate whether HIV infection, ART use, and cocaine use are associated with mitochondrial damage, individually and in combination, and whether mitochondrial damage is associated with the presence and development of cardiac steatosis. If mitochondrial toxicity is found to be one of the underlying causes for the associations, and some medications are found to be associated with mitochondrial damage, preventive measures could be taken to reduce the incidence of cardiac steatosis. It is likely that no one single mechanism, but rather a combination of several mechanisms may lead to cardiac steatosis. We propose that the HIV/ART/cocaine-resultant mitochondrial damage will compromise cardiac fatty acids metabolism, ultimately leading to cardiac dysfunction. Hypothesis 12. Mitochondrial damage is associated with the presence and development of cardiac steatosis and regional LV dysfunction. Hypothesis 13. HIV infection, ART use, and cocaine use are associated with mitochondrial damage, individually and in combination. The proposed research is innovative because, to date, HIV infection, ART use, and cocaine use have not been implicated in the presence and development of cardiac steatosis. Moreover, a possible mechanism for heart failure in those who are absent of coronary artery disease has never been described. This study may be the first to explore the mechanisms of premature HIV-related cardiomyopathy, and may lead to a breakthrough in research on prevention/intervention of heart failure in HIV-infected persons and to translation of scientific discoveries into clinical applications.